Regulatory mechanisms of cerebellar lineage development

PROJECT SUMMARY
Granule cells (GCs) constitute over 95% of the cerebellar volume. They receive and integrate sensory,
motor, and non-sensorimotor signals to fine-tune motor behaviors and cognitive tasks. GCs are generated from
transiently proliferating granule cell precursors (GCPs) over a long time extending from early embryonic period
until first postnatal year in human. Accordingly, cerebellar hypoplasia is one of the most common brain
complications in premature infants with poor developmental outcomes. We have very limited basic knowledge
of how GC lineage is established. Our long term goals are to elucidate the regulatory mechanisms of GC lineage
development, and to understand how different risk factors cause cerebellar hypoplasia. A master regulator of
GCP development is the bHLH transcription factor Atoh1 that maintains the GCP fate through activation of its
own expression. This autoregulatory feedback loop is further supported by a cell cycle regulator Ccnd1 that
stabilizes Atoh1 protein from degradation. However, it remains unclear as to how Atoh1 and Ccnd1 expressions
are terminated to enable timely progression from GCPs to GCs. Our preliminary data suggest that Sin3A, a
component of histone deacetylase (Hdac)–containing transcriptional corepressor complex, is essential for GCP
differentiation by epigenetically silencing Atoh1 expression. We have also identified Insm1, a zinc-finger
transcription factor, as a potential partner of the Sin3A-Hdac complex that inhibits Atoh1 and Ccnd1 expression.
Based on these and other preliminary observations, we propose the novel hypothesis that the Sin3a/Hdac/Insm1
complex epigenetically represses Atoh1 and Ccnd1 expression, thereby integrating transcriptional and
posttranslational signals to regulate GCP fate and cell cycle progression. This hypothesis will be tested by
establishing (1) Sin3A function during GC lineage development, and (2) the role of Insm1 in GCP differentiation.

Public health relevance
Project Narrative The cerebellum is essential for motor coordination and learning. Disorders of cerebellar development are associated with neurological diseases such as ataxia, autism, and medulloblastoma. Therefore, elucidating the mechanism that regulates the generation and diversification of different kinds of neurons during cerebellar development will provide the foundation for understanding and eventual treatment of these diseases.